Core E - Outreach, Recruitment, and Engagement Core

PROJECT SUMMARY
The ORE Core functions as bidirectional bridge between our ADRC and the diverse San Francisco Bay Area
(SFBA) communities that are underserved and underrepresented in our center. Our Core works through three
broad pillars of action developed in close collaboration with our community partners: 1) clinical care for adults
with AD/ADRD from vulnerable backgrounds, 2) education on brain health and AD/ADRD for laypersons and
health care providers, and 3) multimodal art- and movement-based engagements for brain health. These pillars
of action serve as the main pipelines of recruitment of cognitively healthy and impaired diverse populations into
our ADRC, including our Chinese American, Latino American and an emerging Black/African American cohorts.
In addition, we promote participant retention through annual research education events tailored to our cohorts,
in which we share individualized research visit summaries that outline the main clinical findings and
recommendations stemming from each research visit with the participants and their primary care providers.
Moreover, our ORE Core has developed an innovative outreach approach that targets communities living in the
most vulnerable neighborhoods of San Francisco, with neighborhood vulnerability measured across various
social determinants of brain health (SDOBH). We couple this outreach approach with our center’s SDOBH
Project, which aims to construct lifetime exposomes of our diverse ADRC participants based on a multidomain
SDOBH questionnaire created by our ORE Core, with the overarching goal of developing individualized
polysocial risk scores linked with specific brain health outcomes, including AD/ADRD. The ORE Core works to
ensure that our center’s Clinical, Imaging, Biomarker, and Neuropathology Cores can characterize ADRD in
historically underrepresented populations while investigating specific associations between SDOBH factors and
imaging, genetic, fluid-based, and neuropathological biomarkers of AD/ADRD. For this cycle, we will strengthen
our outreach and engagement operations to maintain our existing cohorts of Chinese and Latino American
participants from vulnerable backgrounds, while aiming to recruit and retain a cohort of 30 Black/African
American (20 patients and 10 controls) participants form the SFBA. We will strengthen our community based
participatory research approaches by creating three community based advisory boards (CABs) focused on
further understanding and mitigating barriers to research participation Chinese, Latino, and Black/African
Americans from vulnerable backgrounds. Finally, we will strengthen our educational efforts targeting our partner
community clinics through an innovative program aimed at creating awareness of mild cognitive impairment, mild
behavioral impairment, atypical AD, FTLD spectrum disorders, chronic traumatic encephalopathy syndrome, and
prion disease among primary care providers, to improve referrals of these patients to our ADRC.